Raf-1 As a Regulator of Glutamine Metabolism

PROJECT SUMMARY
The Ras proteins are frequently mutated in cancer to activate diverse signaling pathways necessary
for uncontrolled cellular proliferation, including pathways responsible for regulating metabolism. Ras is
capable of coordinating these many pathways through its many effectors. Though the large number of
tumors driven by HRAS, NRAS, and KRAS mutations makes the protein an attractive drug target, its
structure and complex regulation have limited the development of effective small molecule inhibitors.
Because Ras itself is difficult to target, understanding which of its effectors are critical for its function in
an oncogenic context is necessary. To this end, the Khavari lab had previously conducted a CRISPR
screen of Ras-interactors to identify effectors that were necessary for Ras-driven tumor maintenance.
Across tissue types, we observed a dependence on Raf-1 in oncogenic Ras-driven cancer cells. Follow-
up experiments on Raf-1 revealed that oncogenic Ras induced mitochondrial translocation of Raf-1 and
novel regulators of glutamine metabolism interacting with the protein. Subsequent experiments
demonstrated that loss of Raf-1 led to decreased glutamine metabolism in a mutant Ras-dependent
manner. This work suggests that Raf-1 is a specific vulnerability of Ras-driven tumors due to its role in
directly coordinating metabolic processes. It is well-known that cancer cells rewire their metabolism
and this leads to certain metabolic vulnerabilities, but targeting those vulnerabilities remains a challenge.
This work aims to understand the role of Raf-1 in regulating glutamine metabolism in Ras-driven cancer
cells. We hypothesize that the Raf-1 protein directly regulates glutamine metabolism in Ras-driven
tumors. In Aim I, I will elucidate the impact of Raf-1 on glutamine metabolism by defining the relationship
between Raf-1 and glutamine metabolic enzymes. In Aim II, I will determine the mechanism of Ras-
induced mitochondrial matrix localization. Overall, this work will provide a novel mechanism for Ras-
induced alterations to cancer metabolism.

Public health relevance
PROJECT NARRATIVE The Ras proteins are frequently mutated in a variety cancers, leading to rapid and unrestrained proliferation via the coordination of several pathways, including those responsible for upregulating metabolism. We propose that Raf-1, a Ras effector protein, plays a role in directly regulating several enzymes that are key for glutamine metabolism in Ras-driven cancer cells. This work will provide insight into the role of Raf-1 in the context of Ras mutations and provide a possible avenue for drugging a metabolic vulnerability in these Ras-mutant malignancies.